Predicting urinary continence status with sacral neuromodulation and botulinum toxin treatments

PROJECT SUMMARY
Lower Urinary Tract Symptoms (LUTS) include urinary urgency, incontinence, and nocturia, afflict roughly 50%
of the adult population, and have substantial, wide-ranging impact. Many gaps remain in our understanding of
these symptoms, leading to inadequate treatment.
Urgency urinary incontinence, one form of LUTS, was the focus of two recent multi-site clinical trials
(Anticholinergic vs. Botox Comparison Study or ABC and Refractory Overactive Bladder: Sacral
NEuromodulation vs. BoTulinum Toxin Assessment or ROSETTA). These trials compared the efficacy of
urgency urinary incontinence therapies, 100 Units (U) Onabotulinum Toxin A (Botox) versus an anticholinergic
medication (ABC) and 200U Botox versus sacral neuromodulation (SNM)(ROSETTA). These studies
compared whether on average 100U Botox was superior to a standard anticholinergic regimen (ABC) and
whether 200U Botox was superior to SNM (ROSETTA). The objective of this K01 proposal is to use the same
clinical trial data to create predictive models that accurately estimate the likelihood that a patient will respond to
Botox and SNM treatments, as well as the likelihood of developing urinary retention or urinary tract infections
(risks associated with Botox treatment). In addition to medical histories and questionnaires some of the
predictive models will incorporate diagnostic measurements, both standard and novel, from tests of bladder
function (urodynamics). This approach will allow for the formal assessment of the utility of urodynamics in
guiding treatment decisions, something that is currently debated in the field.
This project will result in innovative models which can be used to: 1) predict whether a patient will respond to
Botox and SNM treatments and the likelihood of adverse events (Botox only); 2) determine the utility of
urodynamics data in predicting patient response to treatment and 3) identify patients that are resistant to
treatment, so as to guide future research. These models will offer a patient specific, data-driven approach to
treatment that will greatly benefit patient care and help reduce costs to the health care system.
This project will also provide training in predictive modeling and clinical benign urology under the guidance of
an experienced mentoring team. The candidate’s long-term objective is to lead a strong independent research
program to design new therapies for patients with (LUTS) informed by both animal and human studies, and to
match patients with suitable therapies based on individual patient characteristics (personalized medicine).

Public health relevance
PROJECT NARRATIVE This project will result in predictive models that clinicians can use to help guide patients when selecting third line therapies for urgency incontinence; providing patients with tailored estimates of how likely it is that they will respond successfully to sacral neuromodulation or intradetrusor Onabotulinum Toxin A. These models will make use of individual characteristics (i.e. personalized medicine), rather than using the current practice, a one-size-fits-all approach, for guiding treatment selection. By improving the match between therapies and patients, it is expected that these models will ultimately improve the quality of treatment that patients receive as well as reduce healthcare costs.